In vivo Sickle Cell Disease Gene Therapy Using a Novel Virus Like Particle

PROJECT SUMMARY
Project Title: In vivo Sickle Cell Disease Gene Therapy Using a Novel Virus Like Particle
Organization: GigaMune, Inc.
PI: David S. Johnson, Ph.D.
β-hemoglobinopathies are the most common monogenic disorders worldwide. These autosomal recessive
disorders affect the normal production of adult hemoglobin due to mutations in the β-globin gene. The two most
common diseases are: i) β-thalassemia, which is characterized by low or absent β-globin production, and ii)
sickle cell disease (SCD), in which a mutant form of β-globin is produced that results in red blood cells (RBCs)
shaped like “sickles” rather than the normal disc shape.
Gene therapies could provide life-long cures for these patients. The FDA recently approved Zynteglo, an ex vivo
manufactured cell-based gene therapy, for the treatment of β-thalassemia and is reviewing two ex vivo gene
therapies (lovo-cel and exa-cel) for β-hemoglobinopathies. Ex vivo gene therapies for β-thalassemia and SCD
remove hematopoietic stem cells (HSCs) from patients, edit the HSCs using lentiviral transgene delivery or
Clustered Regularly Interspaced Short Palindromic Repeats (CRISPR)/Cas gene editing, and infuse the cells
back into patients, with the goal of long-term production of healthy erythrocytes.
In vivo gene therapies are more accessible because they can be administered at most hospitals, and they do
not require myeloablation with busulfan. Lipid nanoparticles (LNPs) and adeno-associated virus (AAV) could be
used in vivo to deliver gene therapies such as CRISPR/Cas machinery for knockout of the B-cell lymphoma 11A
(BCL11A) enhancer, but they are not cell-type specific. Conventional lentivirus is generally not immunogenic on
first dose and delivers larger payloads than LNPs and AAVs. However, conventional lentivirus lacks cell type
specificity.
We have recently used bioinformatics and high-throughput screening to innovate novel lentiviral particles for
engineering genes into T cells, achieving >95% target cell transduction efficiency and >95% cell type specificity.
The Specific Aim of this Phase I SBIR project is to test a novel lentiviral technology for editing HSCs for the
treatment of β-hemoglobinopathies. In Phase I, we will use in vitro assays to assess the efficiency and specificity
of HSC-tropic LV which deliver CRISPR/Cas9 machinery for knockout of the BCL11A enhancer versus HSC-
tropic LV for transgenic expression of anti-sickling βAS3-globin.

Public health relevance
PROJECT NARRATIVE Project Title: In vivo Sickle Cell Disease Gene Therapy Using a Novel Virus Like Particle Organization: GigaMune Inc. PI: David Johnson, Ph.D. Sickle cell disease is one of the most common genetic disorders and currently has no cure. There have been recent advances in cell therapies for sickle cell disease, but these methods remain expensive and can cause infertility. We are working on gene therapy methods that are cheaper and safer for patients.